Structural basis for HIV-1 Nef downregulation of MHC-I: defining the role of membrane interactions in Nef-driven (re)organization of clathrin adaptor AP-1 assemblies

Project Summary
Nef, an HIV accessory protein critical for viral pathogenesis, prevents the adaptive immune system from
detecting and destroying infected cells by downregulating MHC-I surface expression. Nef drives the
mislocalization and degradation of MHC-I by recruiting the major clathrin adaptor protein, AP-1, to the Trans-
Golgi Network and forcing AP-1:MHC-I complexes into clathrin coated vesicles destined for the lysosome.
Structures of Nef in complex with AP-1 and its cofactor, Arf1, in the context of MHC-I binding revealed that AP-
1 trimerization and organization into a lattice could underpin cargo and MHC-I recognition, clathrin recruitment
and subsequent vesicle formation. However, a major remaining gap in this ‘lattice model’ is that the interactions
of AP-1, Nef, and MHC-I occur in, and are organized by, the lipid bilayer; all structures solved to date have been
determined in the absence of a membrane. To fill this major void, the project uses powerful biochemical and
structural tools to uncover the molecular mechanisms of AP-1 and Nef function in the context of membranes. In
Aim 1, AP-1 cargo recognition at the membrane will be reconstituted in vitro and visualized by fluorescence
microcopy in the presence and absence of Nef. AP-1:Arf1 is predicted to form large, punctate structures when
recognizing endogenous cargo, and will specifically require Nef to form punctate structures when binding the
non-cognate cargo, MHC-I. Clathrin is predicted to preferentially associate with punctate structures consistent
with the hypothesis that AP-1 lattice formation underpins cargo recognition, Nef-dependent MHC-I trafficking and
clathrin-mediated vesicle formation. To visualize the physical interactions that drive membrane binding, cargo
recognition and cross-talk within the AP-1 complex, Aim 2 will solve the high-resolution structures of AP-
1:Arf1:Nef complexes bound to MHC-I cargo on nanodiscs by single particle cryo-EM. The near atomic-resolution
structures will unveil critical missing structural information defining how contact with the membrane mediates
Nef-dependent MHC-I recognition by AP-1. Aim 3 will bridge observations made from Aim 1 and Aim 2 by solving
the medium-resolution structure of AP-1 complexes on a bona fide membrane using cryo-electron tomography.
The sub-nanometer resolution electron density maps produced by subtomogram averaging will directly visualize
the organization of AP-1 complexes on membranes for the first time and provide a template to build the first
pseudo-atomic model of AP-1 cargo recognition and Nef hijacking activity. Strategic collaboration with the Collins
and Kirchhoff labs will allow us to test the implications of our findings in vivo, thereby extending the impact directly
to the HIV field. More broadly, the project establishes an in vitro platform for studying HIV accessory proteins
and clathrin adaptors in a biologically relevant environment, e.g. on membranes, of which may be instrumental
in uncovering mechanisms of HIV pathogenesis and/or screening compounds that combat Nef function or enable
greater study of HIV biology.

Public health relevance
Project Narrative HIV Nef restricts the human immune system from detecting replicating and latent viral pools, in part, by hijacking membrane protein trafficking machinery and rerouting key antiviral host receptors away from target membranes. The proposed research builds on previous mechanistic studies by visualizing how Nef mediates MHC-I trafficking through clathrin adaptor protein 1 in the context of membranes. Results from light microscopy experiments and high-resolution structures from cryo-electron microscopy efforts will reveal novel molecular mechanisms of Nef function that potentially open new opportunities for the development of HIV therapies and a cure.